Translation Core

The BREATHE (Bridging Research, Lung Health, and the Environment) Children's Center applies the NIEHS
translational framework to translate findings from for Johns Hopkins Childhood Asthma in the Urban Environment
(CCAUE) Center and other Children's Centers across the country to put science into practice. Novel, evidence-
based communication strategies will inform and engage students, community members, health professionals
and policy makers in efforts to reduce harmful environmental exposures and promote children's respiratory
health. The Translation Core will develop novel tools, including a children's environmental respiratory
health and advocacy training curriculum (Lung Health Ambassadors Program) and a communication
dashboard ( Kids BREATHE Lung Health Dashboard), to address priority opportunities to improve
children's environmental health. The Lung Health Ambassadors Program (LHAP) is a school-based health
education program to educate and empower youth to be advocates for lung health. LHAP was started in
Baltimore City, has been highly successful and has been rapidly implemented in classrooms and online
platforms. LHAP will serve as the foundation for a Children's Environmental Health Curriculum tailored to reach
specific audiences—students, community members, healthcare professionals—with a goal to educate about
environmental hazards that impact lung health and promote interventions to reduce risk. The Johns Hopkins
University COVID-19 Dashboard is an epidemiologic communication tool that has engaged end-users across
the world. The success demonstrates the power of communication tools that are web-based, interactive, and
present information with mapping tools. The Kids BREATHE Lung Health Dashboard will be modelled on the
COVID-19 Dashboard to synthesize decades of research findings to communicate knowledge about
environmental exposures, associated health risks, and the potential benefit of interventions to the general public.
Aim 1 of the Translation Core will synthesize research findings with a state of the science report and develop
these tools with feedback from target audiences. Aim 2 will implement and evaluate the Lung Health Ambassador
Children's Environmental Respiratory Health curriculum and the Kids BREATHE Lung Health Dashboard. Aim
3 will include development of a Lung Health Corps, a volunteer network comprised initially of LHAP graduates
and BREATHE Center affiliates. Key partners at the local, state and national level will be engaged in a
coordinated advocacy program to promote dissemination of communication tools and adoption of policies to
address children's environmental health disparities. This will culminate in the BREATHE Children's Center
Symposium with a Special Session on Public Policy. Aim 4 will support a pilot program that enhances innovation
and engages a diverse pipeline of early investigators, students and community members in all aspects of the
Translation Core activities, fostering career development and engaging future leaders invested in children's
environmental respiratory health.